Cyclin-dependent kinases: Novel switches in anergy and targets for tolerance

DESCRIPTION (provided by applicant): Autoimmunity and organ transplant rejection affect over 25 million Americans, and together have an economic impact of over 100 billion dollars per year. These inflammatory diseases result from a breakdown of the intrinsic regulatory pathways that limit T cell activation and differentiation, and from a failure of regulatory T cells (Treg) t extrinsically suppress conventional T cell (Tconv) proliferation and effector function. Our work during the last two funding periods has focused on the role of cyclin-dependent kinases in T cell differentiation, anergy and tolerance. Our work established critical roles for CDK2 and its inhibitor p27kip1 in controlling the balance between immunity and tolerance. We showed that mice with a germline deletion of CDK2 accept cardiac allografts under conditions that lead to rejection in wild-type recipients, while mice lacking p27kip1 are highly resistant to tolerance induced by costimulatory blockade. Surprisingly, these factors do not operate through regulation of T cell cycle progression. Instead, we found that CDK2 activity promotes T helper differentiation, and that CDK2-deficient Treg exhibit a gain of suppressive activity. In this renewal application, we will explore this exciting new role for the CDK2 pathway in the control of regulatory T cell function, focused mainly by our findings that Foxp3 is phosphorylated and targeted for degradation by CDK2, and that dysregulated CDK2 activity opposes the induction and stability of Foxp3+ Treg. The proposed work will forward our basic understanding of how Foxp3 and regulatory T cell function is regulated, and will also have important therapeutic implications. Small molecule CDK antagonists are currently in phase I clinical trials, and based on our findings, could potentially be used to promote regulatory T cell function and tolerance in autoimmune and organ transplant patients.

Public health relevance
PUBLIC HEALTH RELEVANCE: Autoimmunity and organ transplant rejection affect over 25 million Americans, and together have an economic impact of over 100 billion dollars per year. These inflammatory diseases result from a break down of the 'checks and balances' that normally limit activation of the cells of the immune system. We have identified an unexpected and exciting link between a basic biochemical pathways involved in regulating cell growth, called the cyclin-dependent kinase cascade, and the stability of a factor called Foxp3. This molecule is required to guard against autoimmunity and chronic inflammation, and we have evidence that the cyclin-dependent kinase pathway works against the ability of Foxp3 to do its job. This work will have important therapeutic implications, as small molecule cyclin-dependent kinase inhibitors are currently in phase I clinical trials. Based on our findings, these drugs coul potentially be used to promote Foxp3 function, inhibit inflammation, and reverse immunopathologic disease in autoimmune and organ transplant patients.